Oral THC consumption during adolescence and its impact on adult mouse brain

PROJECT SUMMARY
Edibles that contain Δ9-tetrahyrocannabinol (THC), the principal psychoactive ingredient produced by the
Cannabis plant, are becoming increasingly popular among adolescents, making examination of this method of
use on the adolescent developing brain urgently needed. An ongoing collaboration between the Stella, Land and
Bruchas laboratories led to the development and validation of THC-gelatin voluntary consumption procedures
for rodent and showed that adolescent exposure results in adulthood behavioral impairment due to select
changes in molecular and cellular components in specific brain regions. Here we show that adolescent mice
readily consume THC-gelatin, and that THC-gelatin consumption is increased when adding chocolate flavor
(THC-E-gel) resulting in enhanced acute cannabimimetic effects. This approach can easily be combined with
other drugs, here cannabidiol (CBD), to better understand its pharmacological interaction with THC.
Adolescence represents a critical period where maturation of neural systems is still occurring, particularly in
mesocorticolimbic brain regions, and disruption of this maturation process by drug use may lead to severe
behavioral impairments in adulthood. Our recently published studies highlight one of the first successful voluntary
consumption models of THC in rodents, thereby enabling the study of its long-term consequences on brain
development and behavioral outcomes.
Our new goals are to: 1) determine how long-term adolescent use of select regimens of THC-gelatin alone
or in combination with CBD impact 2) cannabimimetic responses and natural aversive and reward behaviors in
adulthood, which may provide insight as to the mechanism of 3) altered neurotransmission and receptor signaling
within the mesocorticolimbic system. Neuronal activity and endocannabinoid signaling will be measured using
innovative multi-site fiber photometry recoding of behaving animals, and IHC and electrophysiology will be used
to identify structural and circuit changes related to adolescent THC use. Our aims will:
Aim 1: Determine the impact of consumed THC- and THC:CBD-E-gel during adolescence on rewarding,
avoidance, and exploratory behaviors in adult mice.
Aim 2: Isolate how THC:CBD-E-gel consumption during adolescence modifies neural activity across
mesocorticolimbic structures during adult motivated behaviors.
Aim 3: Define specific molecular and circuit changes in adult mesocorticolimbic brain regions resulting
from THC:CBD-E-gel consumption during adolescence.
The completion of these studies, which utilize an innovative mouse model of voluntary oral consumption, will
increase our pharmacological, molecular and cellular understanding of the impact of THC and THC/CBD use on
adolescent brain development, and further determine how such perturbations influence behavior in adulthood.

Public health relevance
PROJECT NARRATIVE Cannabis use by adolescents is rising rapidly and yet little is known about its effect on the developing brain and ensuing consequences on adulthood behavior. This R01 grant proposal will determine the impact of voluntary oral use of the phytocannabinoid, 9-tetrahydrocannabinoid (THC, formulated in gelatin) by adolescent mice on adulthood aversive and motivated behaviors, and whether this impact is dampened by cannabidiol (CBD) co- administration. Our work will increase the mechanistic understanding of the specific dysregulation of brain function that is responsible for persistent behavioral deficits associated with THC use during adolescence.